Impact of chronic alcohol consumption on the functional and epigenetic landscapes of monocytes and their progenitors

SUMMARY
Alcohol misuse is prevalent in the United States, with 10.5% of people ages 12 or older suffering from alcohol
use disorder (AUD) in 2021. Chronic alcohol consumption (CAC) is associated with adverse health outcomes
including increased incidence of infectious diseases, alcoholic liver disease, cancer, cardiovascular disease as
well as impaired wound and bone healing. These findings suggest alcohol misuse negatively impacts the immune
system, and particularly monocytes and macrophages which play critical roles in tissue homeostasis and
antimicrobial defense. During the previous funding cycle, we showed that CAC is associated with elevated
secretion of proinflammatory cytokines and impaired host defense in circulating monocytes and tissue resident
macrophages. Importantly, this phenotype was also observed in bone marrow myeloid progenitor cells, and we
showed that CAC leads to vascular remodeling of the bone marrow niche characterized by a reduction of
primitive hematopoietic stem and progenitor cells (HSPC) as well as a shift in localization of HSPC from an
adipose to a perivascular niche. Moreover, we reported shifts in cell states, chromatin accessibility, and histone
marks with CAC. These findings indicate CAC shifts transcriptional, functional, and epigenetic profiles of
monocytes to a hyper-inflammatory state but the mechanisms by which CAC alters specific subsets of monocytes
and their bone marrow progenitors remain poorly understood. To address this knowledge gap, we will continue
to leverage a well-established macaque model of voluntary ethanol self-administration that recapitulates the
hallmarks of alcohol drinking in humans to test the central hypothesis that dysregulation of the gut microbiota
coupled with the loss of barrier integrity due to chronic alcohol consumption leads to translocation of
microbial products that reprogram monocytes and HSPC towards a hyperinflammatory response with
reduced functional capacity. The novelty of this renewal application lies in the systems biology approach that
integrates metabolomic and functional data with transcriptional and epigenetic readouts at the single cell level in
monocytes and their bone marrow progenitors. Completion of the proposed experiments will uncover the
molecular mechanisms underlying the detrimental effect of CAC on monocytes and their progenitors, thus
enabling a better understanding of the etiology of chronic inflammation caused by CAC.

Public health relevance
NARRATIVE Alcohol misuse is prevalent in the United States and chronic alcohol consumption (CAC) is associated with significant adverse health outcomes including heightened susceptibility to infections and impaired wound and bone healing. These data suggest alcohol misuse negatively impacts the immune system. Using a well- established macaque model of voluntary ethanol self-administration that recapitulates the hallmarks of alcohol drinking in humans, we will investigate the role of CAC-induced alterations in the gut microbiota in reprogramming monocytes and hematopoietic stem cells towards a hyperinflammatory response with reduced functional capacity.